Functional Genomics & Microbiome Core

Project Summary
The Functional Genomics and Microbiome Core (Core C) supports the mission of the DDC and
enhances research programs in its theme of infection and injury affecting the mammalian intestine and
liver. We continue to enhance the scope of the Core, based on DDC user demand and our firm
commitment to the importance of the microbiome in gastrointestinal and liver biology. The emphasis of
this Core is on functional genomics and how genes present in the mammalian microbiome and in
mouse/human genomes may yield functional RNAs, proteins and metabolites that help stitch together
a deeper and mechanistic understanding of digestive diseases. Our mission is to provide a full-service
resource from experimental design to consultations about specimen processing, robust data analysis
pipelines, bioinformatics strategies, and biostatistical support. In summary, we have created a fully
integrated genomic and multi-`omic analysis platform for investigators studying digestive diseases. This
Core serves DDC investigators by providing expertise in microbial and mammalian genomics,
transcriptomics, metabolomics and protein analytics, as applied to gastrointestinal infection and injury
states. Research programs nurtured by DDC members are facilitated by this Core's ability to bridge
microbiome science and mammalian biology, and to provide multi-tiered services at the levels of genes
and effectors (proteins and metabolites). This Core deploys the tools/services of microarrays, deep
nucleic acid sequencing (microbial and mammalian), protein multiplexing, mass spectrometry-guided
metabolomics, and bioinformatics. PCR-based analyses of gene expression and splicing, DNA
mutation/SNP detection, and gene pathway analyses of the mammalian metagenome (microbe and
man) will be fostered by this Core as a platform for gastrointestinal and hepatic systems biology. This
Core presents a combination of shared as well as exclusive offerings to TMC DDC members. The
Microbiome and Mammalian Genomics services provide valuable capital-intensive resources shared
among DDC and non-DDC members at BCM. DDC members account for about 10% of institutional
usage of metagenomics and mammalian genomics services. The Metabolomics/Mass Spectrometry,
Protein Multiplexing, and Bioinformatics services are TMC DDC member-exclusive services, not offered
to non-DDC members as Core functions.

Public health relevance
Project Narrative Per instructions in RFA-DK-17-001 we have not included a project narrative in this application. As specified, we have included the narrative in the overall component.